Investigation of Gastrointestinal Interoception in the Maintenance of Disordered Eating Behaviors

Eating disorders are among the deadliest psychiatric illnesses. High treatment dropout rates and poor
prognosis may be due to existing treatments inadequately addressing dysfunction in gastrointestinal (GI)
interoception (i.e., altered processing of GI sensations). Indeed, aversive conditioning theories of restrictive
eating disorders (i.e., anorexia nervosa [AN], atypical AN, and avoidant restrictive food intake disorder) posit
that heightened GI visceral sensitivity (i.e., constant monitoring and worry about GI sensations) maintains
restrictive eating disorders), yet this has not been tested. This gap is critical, particularly because high dropout
rates during treatment may be because renourishment elicits many of the same GI sensations (e.g., bloating,
fullness) that individuals with restrictive eating disorders fear. Further, it is unclear why individuals with
restrictive eating disorders exhibit altered experience of GI sensations. It may be that these individuals are
responding to different cues than those without an eating disorder due to aberrant GI physiological functioning
(e.g., gastric arrhythmias) or that they are experiencing altered perceptual representation (i.e., interoception) of
normative GI cues. It is critical to examine the mechanisms underlying altered GI experience in restrictive
eating disorders to inform treatment strategies (i.e., medical intervention, GI interoceptive exposures, or both).
Consistent with NIMH’s Strategic Plan Goal 3 and special interest in interoception, this study will contribute
to enhancing interventions for restrictive eating disorders via the following aims: Aim 1: Determine whether
visceral sensitivity leads to the daily maintenance of restricting and compensatory behaviors using ecological
momentary assessment (EMA); Aim 2: Identify mechanisms of altered GI experience (i.e., altered GI biology,
interoception, or both) in restrictive eating disorders and determine the specificity of GI compared to cardiac
interoception for predicting eating disordered behaviors via laboratory tasks and psychophysiology.
The proposed study will recruit adults from a university community screening positive for a restrictive eating
disorder (n = 75) for an EMA study (14 days). The baseline visit includes behavioral measures of interoception
(including GI) and electrogastrography (EGG) and electrocardiography (ECG) recordings. It is anticipated that
greater within-person visceral sensitivity will precede disordered eating behavior, and that within-person
visceral sensitivity will decrease following disordered eating behavior. Compared to a healthy comparison
sample (drawn from the sponsor and co-sponsor’s ongoing collaboration), individuals with restrictive eating
disorders will exhibit altered GI activity and altered GI interoception.
The proposed study offers exceptional training and professional development opportunities for the
applicant, including learning to collect and clean psychophysiology data and conduct analyses in a multilevel
modeling framework. This fellowship will strengthen the applicant’s independent research skills in preparation
for their long-term career goal of obtaining a research position in a high-research output institution.

Public health relevance
Heightened gastrointestinal (GI) visceral sensitivity likely maintains restrictive eating disorders, yet this has never been tested. The proposed research tests whether heighted GI visceral sensitivity maintains restrictive eating disorders (i.e., anorexia nervosa [AN], atypical AN, and avoidant restrictive food intake disorder [ARFID]) and examines possible mechanisms underlying altered GI experience in individuals with restrictive eating disorders (i.e., altered GI physiological functioning, GI interoception). Findings have implications for treatment of restrictive eating disorders, such as shifting treatment targets to directly address heightened visceral sensitivity to increase treatment retention and efficacy.